Sensory Development in Human Cochlear Organoids

PROJECT SUMMARY
This application is in response to the NIDCD Program Announcement PAS-24-058: Advancing Hearing and
Balance Research Using Auditory and Vestibular Organoids. Mechanosensitive hair cells in the cochlea
are essential for hearing, but are vulnerable to damage by genetic mutations and environmental insults,
resulting in irreversible sensorineural hearing loss. The paucity of human cochlear tissues makes it difficult to
study cochlear hair cells and innervating sensory neurons. We recently established a new organoid system
that recapitulates cochlear differentiation. These so called human cochlear organoids contain functional hair
cells, supporting cells and sensory-like neurons. However, the low efficiency of sensory cell derivation and the
lack of mature hair cells and sensory neurons are major limitations for broad pre-clinical applications. We
propose a series of experiments to better understand the genetic regulatory network underlying sensory
differentiation in human cochlear organoids and improve the efficiency of hair cell differentiation and
maturation. In Aim 1, to define the developmental trajectories of key sensory cell types, we will perform a
longitudinal scATAC-seq & scRNA-seq multi-omics analysis of otic lineage cells isolated from human
cochlear organoids at various time points. Additionally, we will develop a new bioinformatics analytical
tool tailored for better integration of temporal multi-modal data by adopting the graph-based neural
networks. In Aim 2, we will test if expanding intermediate otic cell populations by genetic
programming can increase the number of hair cells arising in human cochlear organoids. Our analysis
of longitudinal scRNA-seq data with RNA velocity has identified OTX2 and KLF5 as top candidate
driver genes for intermediate otic cells and nonsensory cells, respectively. We will perform CUT&RUN
to identify direct target genes for OTX2 in otic progenitors. Additionally, we will test if inducible
expression of OTX2 or rapid degradation of KLF5 increases the number of otic intermediate cell
populations, leading to a larger number of hair cells and supporting cells in human cochlear
organoids. In Aim 3, we will test if augmentation of thyroid hormone signaling accelerates maturation
of hair cells and sensory neurons as well as pre-/post-synaptic specification, using a combination of
transcriptomic profiling and morphometric analyses. The results obtained from the proposed
experiments will advance our holistic understanding of cell fate specification in the human cochlea,
offer an improved computational tool for analyzing multi-modal biological data and establish a
valuable human in vitro model system for preclinical applications on sensorineural hearing loss.

Public health relevance
PROJECT NARRATIVE Profound hearing loss is one of the most common sensory disabilities, and caused primarily by loss of sound- sensing cells, called hair cells, in the cochlea. The primary goal of this study is to develop human dish-grown, three-dimensional cochlear-like tissues, so called “human cochlear organoids”, which mimic the structure and function of native human cochleae. These 3D organ replicas will be used to develop and test new hearing restoration therapies.